Radiation and Free Radical

The Radiation Free Radical Research Core (RFRRC) facilitates Holden Comprehensive Cancer Center
(HCCC) researcher investigations that require radiation services or quantitative methods for analyzing
and manipulating redox status and redox based biological changes. It serves both HCCC members and
cancer researchers at other institutions. The RFRRC has been in operation since 1947, and is directed
by Douglas Spitz, PhD; Frederick Domann, Jr, PhD; Garry Buettner, PhD; and Prabhat Goswami,
PhD all of whom have extensive experience and international reputations in free radical-focused cancer
research. The RFRRC provides three basic services. Ionizing radiation services are supplemented by
phosphorimaging and cell-cycle analytical tools critical to understanding basic cellular behavior and
responses to radiation and chemotherapy. Electron paramagnetic resonance spectroscopy and other
analytical chemistry detection methodologies are available for measuring free radicals, singlet oxygen,
small molecule antioxidants, nitric oxide and the array of related oxidants and oxidative damage
products. Antioxidant enzyme services provide easy access to technologies for modifying and
measuring molecules responsible for pro-oxidant formation and oxidative damage. Major equipment
available in the RFRRC includes several radiation sources, a Seahorse analyzer, various types of
spectrophotometers, hypoxia chambers, and equipment for HPLC separation and analyte detection.
The RFRRC provides HCCC members with easy access to specialized knowledge, reagents,
equipment and resources in a highly collaborative and helpful environment.

Public health relevance
PROJECT NARRATIVE Not applicable